Early and life course socioeconomic adversity and dementia risk in Hispanic/Latinos

ABSTRACT
The goals of this administrative supplement to Early and Life Course Adversities and Dementia Risk in Latinos
(1RF1AG077639; contact PI: Isasi) are to (1) address Ethical, Legal, and Societal Implications (ELSI) of
research examining social determinants of health and Alzheimer's Disease and Related Dementias (ADRD)
risk, and (2) develop methods to assess health equity impact of the research. Social epidemiology has been at
the forefront of the identification of health disparities and research to understand its root causes. However, this
area of social epidemiology brings the risks of unintended individual, bystander and groups harms by
contributing to perpetuating the stigma associated with poverty and experienced by minoritized populations,
such as the Hispanic/Latino population. These unintended risks can emerge when: (1) findings regarding
disproportionate ADRD risk are interpreted as failures of the individual rather than of society, (2) findings are
misused or misinterpreted to exacerbate stigmatizing and discriminatory practices, (3) we fail to integrate
community voices and recognize the social context, such as the experience of living with poverty. This
administrative supplement aims to address this important research gap by implementing a model for the co-
design of the study's dissemination strategies and for the interpretation of study results. In addition, this
supplement brings a multidisciplinary perspective building on the ELSI framework. Furthermore, it also
addresses the potential risk of stigma and discrimination based on identified cognitive decline, which may limit
participation cognitive aging and ADRD research for minoritized populations. Another challenge of
observational epidemiological research is that it may be perceived as distant from public health practice,
without a direct action for improving health equity in ADRD or other outcomes. Furthermore, methods for
assessing the health equity impact of observational studies are still lacking. This supplement will adapt a model
for assessing the potential health equity impact of the parent study. In this supplement, we leverage our team
ELSI expertise and the Bridging Research, Accurate Information and Dialogue (BRAID) approach, an
innovative model for incorporating community member perspectives. BRAID will be used to bring community
voices to address the potential for individual and group harms, including stigma, and to move from a deficits
model to a community assets model that aligns epidemiological research with community needs, as we
effectively communicate study findings to maximize impact on structural or policy changes.

Public health relevance
NARRATIVE This administrative supplement addresses the Ethical, Legal, and Societal Implications (ELSI) of research examining social determinants of health and Alzheimer's Disease and Related Dementias (ADRD) risk, by incorporating community perspectives to the interpretation and dissemination of study findings.